Phase Separation-involved Roles of Mediator Complex in Myc-amplified Cancer

ABSTRACT
High frequency of Myc gene amplification is found in many types of cancer, driving the oncogenic activity in
cancer progression. Here I have noticed that the gene encoding one component of the transcription machinery
mediator complex(MED) protein, MED30, is significantly co-amplified with Myc, and thus might complement the
effects of enhanced Myc transcription activity. This correlation suggests a potentially useful adjunct therapeutic
target in Myc-amplified cancer. MED contains thirty components and regulates gene expression by promoting
assembly of the transcription preinitiation complex (PIC) and elongation. My preliminary data has revealed the
unequal structural and functional importance of individual component of MED, by which MED30, located in Tail
module, is required for assemble of at least the Tail and Middle MED modules, while, in contrast, another tail
protein MED15 is not required. Mechanistically, 1,6-hexanediol-disrupted phase separation play a critical role in
it. MED30 depletion leads to protein degradation of many other MED components, while MED15 does not. ChIP-
seq reveals MED is widely enriched in enhancer and active transcribed gene promoters, and regulates target
genes that represents a cancer-associated signature. MED works as a rapid transcription switch in response to
extracellular signals. Therefore, I propose to rigorously test the molecular basis for MED30 function as one of
the core components of MED, linked to cancer exhibiting Myc amplification, which will be the basis for
competitive binding-based drug targeting, and screening for small molecules that can interrupt mediator complex
by high affinity to MED30. I will further explore the molecular mechanism of MED involved transcription regulation
in synergistic with Myc, and investigate the in vivo effect of MED30 inhibition in many cancers, including
pancreatic cancer and a glioblastoma mouse model. This study will simultaneously extend our understanding of
the potential cooperative component of Myc-induced cancer, investigate the roles of phase separation in these
biological events, particularly on the aspect of protein stability regulation important for Mediator function, as well
as how the cells tune their transcriptional program through enhanced MED30 and Myc TF transcription activity.
I will focus on this overlooked and apparently common event in cancer biology, with the goal of providing new
insights into transcription inhibitory drug development and protein degradation-oriented drug targeting strategies.

Public health relevance
PROJECT NARRATIVE The Mediator complex (MED) is one of the key factors in transcription machinery, and we identified Med30 gene is highly amplified in various of cancer patients, and significantly co-amplified with the oncogenic transcription factor Myc. However, little is known about the functional contribution of MED30 to transcription activity of Myc, in synergistic way to promote cancer progression; and how the Mediator big complex stabilizes itself. The proposed studies are aimed at understanding the roles of cancer-related MED30 and MED at the molecular, cellular, and physiological levels, gaining insight into phase separation-involved protein complex stabilizing mechanism, and the potentials of inhibiting MED30 as a therapeutic strategy for disrupting Mediator complex in overactive-transcribed cells including Myc-amplified cancer.